Bcl-2, Subretinal Scar Formation and Neovascular AMD

PROJECT SUMMARY
Age-related macular degeneration (AMD) is a progressive and neurodegenerative disease that affects
individuals typically over the age of 60 leading to vision loss. Inflammation is increasingly recognized as an
important modulator driving choroidal neovascularization (CNV) and subretinal scar formation in neovascular
AMD (nAMD). Although great effort has been given to understanding how to curtail CNV, less is known
regarding the initiation and persistence of fibrosis and subretinal scars. Unfortunately, at least 1/3 of nAMD
patients develop subretinal scars, which are typically associated with unsuccessful anti-VEGF treatment
outcomes. The interrelationship between inflammation, fibrosis, CNV, their termination and the processes
involved is not well defined. We have shown the important role Bcl-2 family members play in these processes.
Bcl-2 is an anti-apoptotic Bcl-2 family member that prolongs inflammation.
Mononuclear phagocytes (MP) play
essential roles in choroidal inflammation, neovascularization, and subretinal scar formation. Our hypothesis is
that unbridled Bcl-2 expression in MP prolongs inflammation resulting in enhanced subretinal fibrosis
and scar formation. Extending cell lifespan, through increased Bcl-2 expression, has a well-documented
negative impact on tissue homeostasis. In this proposal we will take the innovative approach of determining
whether Bcl-2 expression in MP sustains inflammation leading to CNV, subretinal fibrosis and scar formation.
Furthermore, we will utilize several approaches to block Bcl-2 function and increase apoptosis including the
FDA approved Venetoclax (ABT-199), which has been successfully used to treat cancer. The aims proposed
here will determine the extent to which Bcl-2 expression in MP drives persistent fibrosis and subretinal scar
formation following laser photocoagulation mediated CNV. We will examine its impact on inflammation, CNV,
subretinal fibrosis and scar formation and regression when treated with Bcl-2 inhibitors, such as the FDA
approved ABT-199. Delineating the fundamental role Bcl-2 plays in modulating inflammation and subsequent
fibrosis and subretinal scar formation will allow to greatly improve vision outcomes in patients with nAMD.

Public health relevance
PROJECT NARRATIVE The pathogenesis of neovascular AMD (nAMD) is facilitated by inflammation driven subretinal scar formation and choroidal neovascularization, which leads to vision impairment in the elderly. Current treatments are limited and do not address subretinal scar formation which occurs in a significant portion of those with nAMD. The ability to squelch the anti-apoptotic function of Bcl-2 to curtail inflammation, limit subretinal scar formation and improve vision outcomes for patients with nAMD provides a novel treatment modality which is currently lacking.